Respiratory Syncytial virus specific immunity in hematopoietic cell transplant recipients

PROJECT SUMMARY/ABSTRACT
Respiratory syncytial virus (RSV) is a common cause of lower respiratory tract infections (LRTI) in young
children, the elderly and the immunocompromised. For the past year, there have been new RSV monoclonal
antibodies for infants and vaccines for the elderly targeting the pre-fusion F protein, which is projected to
decrease hospitalization rates due to RSV around the world. Although these preventative therapies are
revolutionizing the care for immunocompetent infants and older adults, the efficacy of these therapies in
immunocompromised hosts, including hematopoietic cell transplantation (HCT), recipients, is unknown, since
there are no clinical trial data. With the changing landscape of RSV epidemiology, HCT recipients will remain at
high risk for severe RSV disease due to increased LRTI, which is associated with 20% mortality. Sara Kim,
M.D., a pediatric infectious diseases specialist at Seattle Children’s Hospital and the University of Washington,
developed this career development award proposal to understand the immune parameters associated with
preventing RSV LRTI in HCT recipients. Dr. Kim’s goal is to improve infectious disease outcomes in HCT
recipients through better defining risk for RSV LRTI in this vulnerable population. This proposal builds upon her
training in clinical infectious diseases and provides a detailed plan for career development to expand her
foundations in immunology, vaccinology, biostatistics, bioinformatics, and scientific writing. To assist Dr. Kim to
meet her career goals, she has assembled experts in the field of respiratory viruses in immunocompromised
hosts (Drs. Waghmare and Boeckh), immunology (Drs. Catharine Bollard, Whitney Harrington, and Jim
Boonyaratanakornkit), vaccinology (Drs. Janet Englund and Helen Chu) and biostatistics (Dr. Wang) whom are
dedicated to ensuring the success of this project and the development of Dr. Kim’s career as an independent
clinical researcher.
This proposal will examine systemic and mucosal immune factors in HCT recipients with RSV infection, which
provide protection against LRTI. Subaim 1a assesses humoral immunity, specifically antibodies against all
RSV viral proteins using VirScan, a novel immunosurvey that utilizes phage immunoprecipitation sequencing,
that are associated with prevention of LRTI. Subaim 1b will explore differences in T cell immunity in HCT
recipients with RSV upper versus lower respiratory tract infections. Aim 2 of this proposal will compare
mucosal and systemic antibodies against different RSV proteins using a highly sensitive and quantitative
electrochemiluminescence assay and correlate with protection against LRTI. Through accomplishing the aims
in this proposal, Dr. Kim will contribute significantly to understanding host immune responses in HCT recipients
after natural RSV infection and provide foundations for future vaccine and therapeutics against RSV in this
vulnerable population.

Public health relevance
PROJECT NARRATIVE Respiratory syncytial virus (RSV) vaccines and monoclonal antibodies targeting the pre-fusion F protein are changing the epidemiology of RSV for infants and elderly adults; however, the therapeutic efficacy of these preventative therapies for immunocompromised host, including hematopoietic cell transplant recipients, are unknown. Adult and pediatric hematopoietic cell transplant recipients have altered immunity and the immune responses after RSV are not well characterized. We propose to study the humoral, cellular, and mucosal immune responses during RSV infection in hematopoietic cell transplant recipients to understand the protective factors against progression to lower respiratory tract infection.